IMMUNOGLOBULIN GENE EXPRESSION IN MYELOMA AND LYMPHOMA

The long term goals of this research are to understand the regulation of immunoglobulin heavy chain mRNA processing and expression during normal and neoplastic B cell development. Mouse myeloma tumor cells and lymphoma cells are being used, respectively, as models of plasma cells and earlier B cell stages and memory cells. Differential production of membrane and secretory encoding mRNAs from a single IgG gene has been shown to be regulated by post-transcriptional processing events, differential polyadenylation and/or splicing. We propose to study the mechanism of this regulation by making altered gene constructs and transfecting them back into the myeloma and lymphoma cells to test the role of various cis-acting sequences. Areas of DNA near the membrane encoding poly A sites will be sequenced and compared with the already sequenced secretory poly A sites. In vitro polyadenylation systems from myeloma and lymphoma cells will be established. Requirements for cis-acting sequences and putative trans-acting, stage-specific factors will be investigated in the vitro system. The role of transcription termination sites in regulated membrane and secretory mRNA production will be investigated by transcription run-on assays, analysis of nulcease resistant species, DNA sequencing and tests for biological functionality. Differences in transcription rate alone cannot account for the tremendous differences observed in immunoglobulin mRNA abundancies during B cell development. We propose to measure immunoglobulin heavy chain mRNA turnover in cells representing different B cell stages and correlate these with abundancy, transcription rate and nuclear transport and stability.